Cyclic Immunofluorescent Imaging in Live Cells

PROJECT SUMMARY/ABSTRACT
Cancer is a heterogeneous and dynamic disease that evolves throughout the course of treatment. Single-cell
technologies have shown that the composition of tumors and the tumor microenvironment impact treatment
efficacy. As such, it is challenging to predict which patients will optimally respond to current or next generation
therapies (e.g. checkpoint inhibitors, cell therapies), and almost impossible to predict when or why a treatment
will fail. To capture complex cellular functions and biological processes, methods need to be as dynamic as the
cells they measure. The goal of this project is to determine the feasibility of using Aperture Bio’s platform for
pre-clinical applications in drug development applications in organoids, as well as process development and
research applications in cell therapy manufacturing, regenerative medicine, cell developmental biology, as well
as oncology. The successful completion of this project will determine if Aperture Bio’s platform is suitable for
the rigor required in these applications to improve current precision medicine development and delivery
approaches. conjugation and quenching technologies can stain and quench live cells in multiple cellular
compartments (e.g. membrane, cytosol, and nucleus) and quantify any cellular perturbations caused by
multiplexed cycling.

Public health relevance
PROJECT NARRATIVE Cancer is a dynamic disease that evolves throughout the course of treatment, but current clinical tools are limited to one biomarker measured at one point in time. This project prototypes a platform to measure many targets across time points, with the ultimate goal of accelerating precision medicine and drug development to improve patient care.